Neural Circuit Mechanisms of Allogrooming Behavior

Project Summary/Abstract
Affiliative social interactions play an essential role in the reproduction and survival of social species including
humans. Its disruption in neuropsychiatric conditions or during times of social isolation such as the COVID-19
pandemic can take a heavy toll on mental and physical well-being. However, the neural circuit mechanisms
governing affiliative social behaviors are not well understood. Allogrooming (grooming behavior directed toward
another individual) is a major form of affiliative social contact through which animals may form, maintain, and
strengthen social relationships and is conserved in a wide range of social species, such as birds, bats, rodents,
canids, cats, equids, and primates. However, the neural circuitry underlying allogrooming has been sparsely
explored and few brain areas that encode and promote affiliative allogrooming have been identified. Deciphering
the neural circuit mechanisms of affiliative allogrooming will provide key insights into the neural basis underlying
social affiliation and attachment. Given the prominent impairment in affiliative social behavior in several
neuropsychiatric disorders, including autism and schizophrenia, this understanding can guide circuit-level
investigation of disease mechanisms and development of interventions. In recent studies, we established an
ethologically relevant and experimentally tractable paradigm for studying allogrooming behavior in laboratory
mice and uncovered a key role of a medial amygdala (MeA)-to-medial preoptic area (MPOA) circuit in controlling
this behavior. These findings open up valuable opportunities for in-depth dissection of the functional circuitry
underlying allogrooming behavior. The central objective of this application is to elucidate the neural circuit
mechanisms through which the MPOA controls allogrooming, which represents a critical next step toward
defining the functional organization of the neural circuitry of affiliative social behavior. We propose a series of
experiments to comprehensively probe whether and how the activity of select MPOA neuronal subpopulations
and their downstream targets regulate allogrooming behavior. Specifically, we will address the following
important questions: (Aim 1) Is allogrooming behavior controlled by select, molecularly defined MPOA
subpopulations? (Aim 2) Whether and how neural activity dynamics in MPOA neurons encodes social sensory
cues and allogrooming behavior? (Aim 3) What are the neural circuits downstream of the MPOA that mediate
allogrooming behavior? Our proposed research will integrate state-of-the-art techniques for functional
manipulation of specific neuronal subpopulations, in vivo imaging of neuronal activity dynamics in awake, freely
behaving animals, and functional mapping of neural projections to reveal how specific MPOA neuronal
subpopulations respond to conspecific cues and control the display of allogrooming through their downstream
projections. This investigation will yield novel, critical insights into the neural circuitry underlying an evolutionarily
conserved, major form of affiliative social behavior. Such insights will impact our understanding of social
cohesion and disconnection, such as in individuals experiencing social isolation or neuropsychiatric disorders.

Public health relevance
Project Narrative Social behaviors are essential for the mental and physical well-being of social species including humans; abnormalities in social behaviors are major symptoms in a host of mental disorders, such as autism spectrum disorders and psychopathy. The proposed research is relevant to public health because it studies the fundamental mechanisms that regulate an important form of social behavior. The proposed research could help reveal fundamental principles that are potentially applicable to the human brain, and could help guide investigation of disease mechanisms and development of effective treatments for human mental disorders.